PATHOGENESIS OF AUTOIMMUNITY IN INBRED STRAINS OF MICE

The genetic control and immunologic mechanisms of autoimmune disease is being investigated in the New Zealand strains of mice, their F1 hybrids, and recombinant-inbred lines derived from them. We have found 1) that enlargement of Lyt-2+ T cells is significantly associated with the titer of anti-erythrocyte autoantibody and degree of hemolytic anemia; 2) T cell suppression is defective in old NZB mice; 3) NZB, and particularly the (NZB x NZW) F1 hybrid, has a major resistance to induction of tolerance in the T cell subpopulation; 4) several abnormalities of proteins synthesized by lymphocytes from NZB mice can be demonstrated by two-dimensional gel electrophoresis. One, 16 kd in size, is observed only in enlarged NZB B cells, and may be associated with their pathologic spontaneous activation.